EFFECT OF AF102B ON AMYLOID PROCESSING IN ALZHEIMERS DISEASE

This is an exploratory pilot project designed to obtain biochemical support for developing treatments that prevent amyloid deposition in branis of Alzheimer's patients.